Cell-cell and cell-matrix interactions driving progressive fibrosis in interstitial lung diseases

Project Summary
Interstitial lung diseases (ILD) are a large group of lung diseases that are characterized by chronic, progressive
pulmonary fibrosis. We hypothesize that in all ILDs the progressive fibrosis is driven by ongoing injury/stress in
the airway epithelial cells that set up crosstalk with their neighboring mesenchymal cells resulting in a chronic
wound healing process that alters the matrix and changes the cellular niche. The goal of the proposed research
is to address how interactions between the epithelial, mesenchymal and matrix compartments drive progression
of fibrosis in all forms of ILD. We are proposing to study these interactions between the epithelial, mesenchymal
and matrix compartments, which is now feasible with spatial transcriptomics, single cell secretion protein
analysis, and small region proteomics. Most studies have looked at end stage disease and fibrotic lesions where
most of the epithelial cells are lost and consequently the initiating and propagating factors are not well
understood. We propose to study Interstitial Lung Abnormality (ILA) lesions, which represent very early ILD
lesions, early stage ILD lesions when patients start to become symptomatic, and late stage ILD regions that still
contain epithelial cells so we can study their interactions with mesenchymal cells and matrix. To test our
hypothesis, we have developed a 3D scaffolded lung cell co-culture model system with progressive fibrosis that
closely models these cellular compartments in ILD tissue. We propose the following aims:
Aim 1: To understand epithelial-mesenchymal interactions in the airway that drive fibrosis using spatial
transcriptomics. We will use our biobank of ILD and ILA samples and prospectively collect ILD and ILA patient
samples to profile the airway epithelium and underlying fibroblasts from bronchioles to distal airspaces with
spatial small region transcriptomics (GeoMx) and single cell spatial genome-wide transcriptomics (Stereoseq).
Aim 2: To understand epithelial, mesenchymal and matrix interactions in the airway that drive fibrosis.
Aim 2a: We will use the secretory-single cell profiling (Sec-seq) technology to capture single airway epithelial
cells, from fresh ILA and ILD tissue and trap the secretions from each cell to identify paracrine factors.
Aim 2b: We will use nanoscale small region proteomics to identify proteins in the adjacent epithelial,
mesenchymal and basement membrane matrix compartments from ILA and ILD samples.
Aim 3: To identify mechanisms by which persistent airway injury induces progressive fibrosis by using cell co-
culture models of iPSC derived AT2 cells with specific mutations associated with familial IPF, in conjunction with
primary healthy or IPF lung fibroblasts. These powerful reductionist models allow the study of specific epithelial-
mesenchymal-matrix interactions that drive progressive fibrosis.
We have assembled a team with expertise in spatial transcriptomics and ILDs (Gomperts), novel bioinformatics
pipelines and integration of genomics data (Plath), regional small-scale proteomics in ILDs (Clair), iPSC-derived
AT2 disease modeling and ILDs (Kotton) and bioengineered models of ILD (Gomperts).

Public health relevance
Project Narrative Our overarching goal is to understand how fibrotic lung diseases arise and how they progress and we will therefore collect samples from these patients and analyze the individual cells in the tissue in their locations and study how they interact with one another. We will also examine what each of the cells is secreting and how this could drive progression of fibrosis. Lastly, we will use our human 3D model of lung fibrosis to test specific ways in which cell interactions might drive fibrosis.